The genomic and epigenomic landscape of otosclerosis

SUMMARY
Otosclerosis is an age-related bone disorder characterized by pathological remodeling in the otic capsule of
the temporal bone, leading to stapedial fixation and hearing loss. The disease is typically bilateral, progressive,
and commonly affects women more than men, with onset usually occurring in the 3rd or 4th decade of life.
Although conductive hearing loss can be managed through hearing aids or stapes microsurgery, other clinical
features such as sensorineural hearing loss, tinnitus, and vertigo pose greater challenges in treatment.
The pathophysiology of otosclerosis it still poorly understood. The otic capsule has a uniquely low bone
turnover rate, a process that is disrupted in otosclerosis for unknown reasons. Genetic factors play a critical role
in the disease's development, and our preliminary findings, along with others', suggest a genetic overlap with
other skeletal disorders. Additionally, while epigenetic mechanisms have been strongly implicated in other aging-
related bone diseases, research on their role in otosclerosis is even more limited.
Our proposal aims to uncover the molecular basis of otosclerosis by utilizing advanced genomic and
epigenomic techniques on a large cohort of unrelated otosclerosis cases and families. This previously gathered
cohort, resulting from a long-standing coordinated endeavor by the research team, provides an exceptional
opportunity to investigate the molecular aspects of otosclerosis and identify novel genes implicated in the
disease. To achieve our aims, we will: 1) Analyze ultrarare and rare genomic variants in a set of large families
segregating otosclerosis via genome sequencing. 2) Study common and rare genomic variants in a large cohort
of otosclerosis cases and controls via a genome-wide association study using a blended genome-exome
sequencing strategy
. 3) Identify epigenetic factors implicated in otosclerosis via genome-wide methylation
profiling in cases and controls and multi-omics integration of genetic and epigenetic data. All aims are
independent and complementary. By the end of this study, we expect to have gained a great insight into the
molecular background of otosclerosis. Our results may aid in the development of therapeutic interventions,
diagnostic screening, patient management, and family counseling.

Public health relevance
NARRATIVE This proposal leverages genomic and epigenomic techniques in an assembled large cohort of families and unrelated cases to unravel the molecular etiology of otosclerosis, an age-related disorder characterized by an abnormal bone remodeling in the otic capsule. Findings from this study may aid in risk prediction, screening, patient management and treatment.